Proteomics profiling in hypertrophic cardiomyopathy and cardiac event prediction

PROJECT SUMMARY
Hypertrophic cardiomyopathy (HCM) is the most common genetic cardiac disease and causes
major adverse cardiovascular events (MACE) – e.g., arrhythmias, heart failure, and sudden
cardiac death. Invasive interventions to prevent MACE are available but can cause
complications. Current risk stratification strategy has limited power to predict which patient
would develop MACE and benefit most from preventive interventions. Furthermore, little is
known about the signaling pathways through which gene mutations mediate HCM pathogenesis
and MACE. These major knowledge gaps have hindered efforts to prevent MACE in HCM. The
Harvard-Columbia Multi-center Hypertrophic Cardiomyopathy (HCM2) Biorepository is an
ongoing 3-center cohort study that enrolled 560 patients with HCM during 2014-2020. In this
large multi-center HCM biorepository, investigators have collected high-quality biospecimens –
e.g., plasma, left ventricular myocardium. Follow-up data include biannual interviews, medical
record reviews, and in-person exam every year, with >85% follow-up to date (median follow-up,
3.1 years). The present R01 project will extend this large well-characterized HCM biorepository
by proteomically profiling both plasma and myocardium samples, and by examining their
relations to both HCM disease status and MACE. In Aim 1, we will examine the association of
signaling pathway dysregulation in the myocardium with HCM disease status using molecular
biology approach (e.g., RT-PCR of mRNA, ELISA) and proteomics profiling. In Aim 2, we will
determine the association of signaling pathway dysregulation with MACE using proteomics
profiling, and specify signaling pathways that predict incident MACE. Finally, using a systems
biology approach, Aim 3 will define HCM subtypes by integrating proteomic, genetic, and clinical
data, and determine their associations with MACE. Our prior study and preliminary work lend
compelling support to our hypotheses. The present R01 project will provide a unique opportunity
to reveal the molecular mechanisms of HCM pathogenesis and progression to MACE through
examining signaling pathways using proteomics profiling in both plasma and myocardium.
Furthermore, the proposed study will also invent a novel risk stratification system in HCM, which
will allow us to precisely identify high-risk HCM subpopulations that would benefit from
preventive interventions. The project will provide a strong evidence base for developing targeted
pharmacotherapies to prevent HCM pathogenesis and MACE through the modulation of specific
signaling pathways. The investigators have integrated and complementary expertise in all
relevant fields. The study matches well with the NHLBI strategic plan for HCM research.

Public health relevance
PROJECT NARRATIVE Hypertrophic cardiomyopathy is the most common genetic cardiac disease and causes a variety of cardiovascular events such as arrhythmias, heart failure, stroke, and sudden cardiac death; however, effective pharmacotherapies to prevent disease manifestation or cardiovascular events are not available. In an ongoing, large multi-center cohort of patients with hypertrophic cardiomyopathy, the investigators will define the role of signaling pathway dysregulation in disease pathogenesis and the development of cardiovascular events by performing proteomics profiling in both plasma and myocardium. This research has the potential to identify potential molecular targets for the prevention of disease manifestation and progression, and to offer novel approaches to specify high-risk subpopulations that benefit most from preventive interventions.